Immunology core

Project Summary (Immunology)
Continuing funds are requested by 18 vision scientists (holding 20 eligible NEI R01 grants) and their
personnel to support three resource cores and an administrative core in the merged Department of
Ophthalmology, Visual and Anatomical Sciences (former Ophthalmology and Anatomy/Cell Biology
Departments). The Immunology (I-Core) will be directed by Dr. Ashok Kumar, an R01-funded
investigator with significant expertise in immunological techniques. Together with the PI, and a research
assistant, the environment and capability to conduct vision research at Wayne State University and
affiliated institutions will be enhanced through prioritization of the work of NEI R01 funded investigators,
their staff and students (graduate and fellows) in numerous aspects of Immunology. This core will
ensure vision researchers have ongoing access to contemporary instrumentation and approaches in
flow cytometry/FACS and other immunological assays to facilitate their research. The I-core maintains
flow cytometry, western blotting, ELISA, and other capabilities that enable advanced cell analyses for a
wide range of research areas. The experimentation supported by the I-core will continue to provide
sophisticated immunological assays and expert consultation/training to the vision research community,
maximize and centralize specialized immunology research tools, and initiate and stimulate innovative
research projects addressing emerging questions of eye diseases. Priority for NEI R01 funded
investigators at Wayne State University (WSU) and other affiliated institutions (Oakland University) will
be provided. The I-core also provides a supportive environment to foster collaboration among NEI R01
funded investigators, clinicians, and other WSU and affiliated investigators to develop and carry out
basic and translational vision research. The I-core also will provide support, at reduced priority, for new
investigators, and/or others who are collecting preliminary data to be used for NEI R01 grant
submission.